Quantitative modeling of extrachromosomal DNA (ecDNA) evolution in tumors

Project Summary. Cancer is governed by evolutionary principles whereby sequential changes at the genetic
and epigenetic level enable proliferation, immune evasion, drug resistance, and metastasis. An outstanding goal
in cancer biology is to understand the spatiotemporal processes underpinning this evolution. To do so would
greatly improve our ability to create more effective treatment strategies and forecast tumor development far into
the future. However, this goal remains elusive due to our incomplete catalog of molecular processes driving
evolution and lack of molecular and computational tools for holistically profiling tumors.
One emerging driver is extrachromosomal DNA (ecDNA). Found in approximately half of cancers and
strongly associated with poor survival, ecDNAs are a unique form of oncogene amplification: they reside outside
of chromosomes and exhibit elevated copy-number, gene expression, and chromatin accessibility as compared
to chromosomal amplifications. New evidence has underscored the importance of ecDNA dynamics and
heterogeneity in driving tumor progression: first, ecDNAs asymmetrically segregate during mitosis, leading to
accelerated copy-number gains and rapid adaptation to stressful conditions. Second, several varieties of
ecDNAs can exist in single cells where they form cooperative, intermolecular “hubs”. Despite this appreciation,
these features of ecDNA have remained elusive to study due to a scarcity of tools for profiling their vast
heterogeneity and stochastic evolutionary dynamics. In this project, I will develop the requisite computational
tools for profiling ecDNA variability and evolution in cancer and use these tools to more thoroughly investigate
how ecDNA heterogeneity is created, maintained, and leveraged in response to targeted therapies. First, I will
build on breakthroughs in long-read sequencing to develop tools that enable unbiased multi-omic profiling of
ecDNA variability across biological conditions (Aim 1). Second, I will leverage new molecular techniques to infer
the phylodynamic properties of ecDNA lineages and learn the molecular fitness landscape of ecDNA (Aim 2).
Third, I will explore the co-evolutionary principles of ecDNA by combining evolutionary modeling and CRISPR-
based screens (Aim 3). Together, these studies will illuminate properties of ecDNA evolution, nominate new
therapeutic strategies, and provide innovative computational tools for the greater scientific community.
This work will be performed in the excellent training environment of Stanford University under the
mentorship of Dr. Howard Chang, an expert in epigenomics and ecDNA. An advisory committee of leaders in
the fields of ecDNA, cancer biology, bioinformatics, and tumor evolution will provide additional expertise and
mentorship. The first half of each aim will be completed predominantly during the K99 phase of the award,
providing a solid foundation for the aims in the R00 phase and eventually an independent R01 application.

Public health relevance
Tumor evolution is often the cause of outstanding clinical challenges, such as acquired drug resistance and metastasis. Recent work has demonstrated that oncogene amplification on extrachromosomal DNA (ecDNA) is a major driver of tumor evolution but remains difficult to study due to its elusive evolutionary dynamics and substantial variability. This project proposes the development of innovative new computational tools that will illuminate ecDNA heterogeneity and evolution at unparalleled resolution, which will in turn be used to nominate new therapeutic strategies that target ecDNA-mediated tumor evolution.